Developmental Research Program

PROJECT SUMMARY - DRP
The Wisconsin Head and Neck (HN) SPORE Developmental Research Program (DRP) will provide Pilot Project
funding to support new, innovative and high impact research in Head and Neck Cancer (HNC). A coordinated
process through the HN SPORE Administrative Core (Admin Core) will ensure that an effective and efficient
mechanism is in place to successfully solicit, review, select, advise, and monitor DRP projects to ensure that
resources are used effectively. The HN SPORE DRP funding will provide financial support to highly meritorious
applications to conduct translational research focused on 1) diagnosis of HNC, 2) identification of novel
biomarkers and imaging modalities in HNC or HNC progression, 3) understanding disease-causing mechanisms
in HNC, 4) treatment of HNC, and 5) prevention of HNC. The DRP will supplement and enhance an existing
mechanism at the University of Wisconsin Carbone Cancer Center (UWCCC), which supports early cancer
explorations and translational research collaborations through Pilot Projects and Multi-Investigator Planning
Grants as part of the discovery translation mission of the UWCCC. The DRP will have an annual budget of
$150,000 ($50,000 from the HN SPORE and $100,000 in matching institutional funds) to provide to projects that
are reviewed to be meritorious. The long term goal of the Wisconsin HN SPORE DRP will be to stimulate new
research that leads to a reduction in the incidence and mortality rates of HNC. This process will include (a)
publicizing the availability of DRP funds in translational HNC research in order to solicit projects that are
innovative, high risk/high impact, and have significant potential for reducing HNC incidence, morbidity, mortality
or for increasing survival; (b) use criteria established in previous funding period for the competitive selection of
meritorious projects from peer-review which scores and ranks competing applications; (c) providing funds for
HNC developmental research, and (d) provide effective evaluation of funded projects to monitor, mentor and
ensure success. The DRP will ensure efficient, progressive and successful conduct by investigators consistent
with the program goals and HN SPORE mission, designed to provide a multidisciplinary interactive environment
for collaboration and the fostering of translational research ideas.